Cognitive SuperAging: A model to explore resilience and resistance to aging and Alzheimers disease

PROJECT SUMMARY/ABSTRACT:
Memory complaints are widespread among the elderly and aging is a major risk factor for Alzheimer's disease
(AD), leading to the impression that a gradual loss of memory ability, eventually culminating in dementia, may
be a nearly universal consequence of getting old. Our studies explore an alternative aging trajectory by
studying 80+ year olds, who have episodic memory performance that appears to have escaped age-related
decline and that remains in the range that is at least normal for 50-60 year-olds and we have labelled
`SuperAgers'. We enrolled a dedicated and unique cohort of SuperAgers and Controls committed to
longitudinal assessment and brain donation at death. Our initial studies identified domain-specific biologic,
psychosocial, and genetic features of the SuperAgers, including maintenance of cortical integrity (especially in
the anterior cingulate), an abundance of anterior cingulate Von Economo neurons and sparse cortical
Alzheimer pathology compared to their cognitively average peers. These features may contribute in part to
maintenance of superior memory performance past the 8th decade of life. This Project plans to extend the
characterization of the SuperAging phenotype through hypothesis-driven novel evaluations of functional brain
network connectivity, regional distribution of gene expression, and integrity of dendritic, synaptic and axonal
markers. The proposed project will allow us to expand our unique group of SuperAgers and cognitively
average peers and address important questions related to the neurobiology of resilience and cognitive reserve.
By identifying neurobiologic features that contribute to superior memory performance in old age, outcomes
from this project will help isolate factors that promote successful cognitive aging and perhaps also prevent age-
related brain diseases such as AD. The project's reliance on a cohort that has already been partially recruited,
its longitudinal design, multidisciplinary structure, and collaboration-friendly organization increases the
likelihood that consequential progress will be achieved.

Public health relevance
PROJECT NARRATIVE: The proposed research will characterize, in an interdisciplinary and longitudinal manner, a cohort of 80+ year- olds who display exceptionally successful cognitive aging and whom we have termed SuperAgers. This proposal will explore the mechanisms of the unique biologic and genetic features associated with SuperAging. The identification of these factors may make it possible to help elderly maintain cognitive strengths and prevent Alzheimer's disease.